Elucidation of JUNV GPC Structure and Molecular Mechanisms of Escape from Humoral Immunity

Elucidation of JUNV GPC Structure and Molecular Mechanisms of Escape from Humoral Immunity
Junin virus (JUNV) is a New World arenavirus and causes Argentine hemorrhagic fever. The JUNV
glycoprotein complex (GPC) on the surface of virions mediates viral entry by binding to the host protein,
transferrin receptor 1 (TfR1). GPC is synthesized as a single polypeptide precursor that undergoes cleavage by
the cellular protease SKI-1/S1P to yield subunits GP1 and GP2, which function in receptor binding and
membrane fusion, respectively. Unique to arenaviruses is the stable signal peptide (SSP) which is retained in
the mature spike glycoprotein complex and is critical for GPC stability and post-translational processing.
Currently, all characterized JUNV neutralizing antibodies (nAbs) target the receptor binding site (RBS)
within the GP1 domain. However, the RBS of New World arenaviruses is highly diverse in sequence despite
sharing a common binding mode to their receptor, TfR1. This suggests there may be a broad mutational
landscape compatible with TfR1 utilization, potentiating escape from RBS-directed antibodies. Importantly, a
recent study demonstrated that MACV GPC can readily escape RBS-directed nAbs isolated from vaccinated
mice. Our lab previously characterized a panel of nAbs targeting the RBS of JUNV, with one nAb in particular
showing significant therapeutic efficacy in mice and guinea pig models. However, the propensity of JUNV to
escape from nAbs, including this particular nAb, has not been investigated. Therefore, this proposal aims to
examine the molecular mechanisms and evolutionary dynamics of JUNV escape by passaging VSV
pseudotyped with JUNV GPC in the presence of these RBS-directed antibodies. By using a similar approach
with convalescent sera depleted of GP1-directed antibodies, I will map nAb epitopes outside of GP1. The role of
epitopes outside of GP1 in sera neutralization has not been explored and experiments proposed herein will
elucidate whether they represent additional targets for vaccine and therapeutic development. Epitope information
obtained will enable to design of antigenic probes for sorting B-cells specific for these epitopes in future studies.
Efforts to study nAbs targeting epitopes outside of GP1 are hindered by the lack of GPC reagents critical
for their isolation and characterization. Efforts to develop these stable New World GPC antigens are complicated
by the lack of high resolution structures for use in rational protein design. Therefore, another central aim of this
proposal is to obtain the structure of JUNV GPC by cryo-EM. If successful, the resulting model will be used for
structure-based stabilization of the GPC. A stabilized JUNV GPC trimer would not only serve as a valuable
research tool and promising vaccine antigen but would also provide a blueprint for structural characterization of
other New World arenaviruses. Taken together, the research in this proposal will identify pathways for antibody
escape in JUNV GPC, define novel neutralizing antibody epitopes, and provide a high-resolution structure of
JUNV GPC to help inform vaccine and therapeutic antibody design efforts.

Public health relevance
Project Narrative Junin virus (JUNV) is a pathogenic New World arenavirus and the etiological agent of Argentine hemorrhagic fever (AHF), which carries a mortality rate of 15-30% in humans. Currently little is known about the neutralizing antibody response against JUNV, and recent studies suggest it may be able to escape monoclonal antibodies (mAbs) undergoing preclinical development. Using structural biology and a pseudovirus passaging system, we will determine potential avenues of mutational escape from current mAbs, identify novel neutralizing epitopes, and obtain the structure of a prototypical New World arenavirus glycoprotein complex.